59th Annual Meeting of Nobel Prize Laureates and Students

This interagency transfer to the United States Department of Energy supported attendance by approximately 15 graduate students at the 59th Lindau Nobel Laureates Meeting in Lindau, Germany, in June-July 2009. Institutions nominate outstanding U.S. doctoral students to participate.